Mitochondrial Transfer to Treat SBMA Motor Neurons

Project Summary
Spinal bulbar muscular atrophy (SBMA) exhibits mitochondrial abnormalities. We and other
investigators have shown that mitochondrial dysfunction in SBMA involves both loss and gain of function from
the mutant androgen receptor (AR), acting as a critical driver to motor neuron (MN) degeneration. The
proposed project aims to implement mitochondrial transfer to treat SBMA MNs. Our specific aims for this
project will be as follows. In Specific Aim 1, we will develop an isogenic human neural stem cell (NSC) model,
consisting of isogenic control, disease, and AR knockout lines. We will isolate extracellular vesicles (EVs)
secreted from different isogenic NSC lines and specify biological characteristics of these vesicles for new
biomarker identification. In Specific Aim 2, we will culture disease MNs by supplementing mitochondrial EVs
derived from the isogenic control NSCs. We will examine the EV uptake potential of disease MNs, track the
intracellular fate of transferred mitochondria in recipient neurons, and evaluate whether EV-mediated
mitochondrial transfer will attenuate SBMA pathology. This project will establish the rationale and validate the
feasibility of mitochondrial transfer as a novel neuron-type-specific therapeutic intervention for SBMA and
other related neurodegenerative and neurologic disorders.

Public health relevance
Project Narrative The proposed research will utilize mitochondrial transfer to rescue motor neuron-related mitochondrial dysfunction in spinal bulbar muscular atrophy (SBMA), an X-linked neuromuscular disorder. The goals of the proposed research are to identify new biomarkers for SBMA and to establish the rationale and validate the feasibility to harness neural stem cells as an efficient mitochondrial supplier to treat disease motor neurons. This work will help establish a clinically translatable platform for human induced pluripotent stem cell-based therapeutic intervention for SBMA and other related neurodegenerative and neurologic disorders.